A Multidimensional Dissection of Antipsychotic Treatment Response in Early Schizophrenia

PROJECT SUMMARY Coping with stress is a pervasive issue in day-to-day life, with chronic stress unearthing neuropsychiatric disor- ders in susceptible individuals. Stress-induced disorders include massive public health issues such as anxiety, depression and addiction. Despite our knowledge of the clinical pathologies associated with stress, the precise neural substrates of stress signaling remain unclear, and it is thus exceedingly difficult to develop therapeutic strategies for certain neuropsychiatric disorders. One brain region influenced by chronic stress is the ventral tegmental area (VTA), a heterogeneous midbrain area. The VTA is cellularly diverse, possessing dopaminergic (DA), GABAergic (GABA) and glutamatergic (Glu) neurons that together govern and coordinate motivated be- haviors. It is challenging to interpret the impact of chronic stress on VTA neurophysiology, as VTA neurons display differing firing patterns depending on the context, longevity and intensity of the stressor. It is also likely that there are cell-type-dependent responses to stress in the VTA. Therefore, I hypothesize that chronic stress elicits cell-type-specific transcriptional changes, leading to functional adaptations in VTA neuronal activity. To critically test how chronic stress impacts VTA neurophysiology, I propose to directly and chronically administer corticosterone (cort) to male and female mice. Following cort administration, I will first employ Drop-seq, a high- throughput single cell RNA-seq (scRNAseq) method, to profile VTA gene expression changes at a single-cell level resultant from chronic stress (Aim 1). Next, I will utilize patch-clamp electrophysiology and single-cell qPCR to measure membrane properties and synaptic activity of stress-modulated VTA neurons in a cell-type-specific manner. Using single-cell qPCR, I will measure changes in not only stress signaling- and neurotransmitter-re- lated genes, but will also measure alterations in genetic markers identified from Drop-seq (Aim 2). Here, I will attribute physiology and anatomy to gene expression, providing a more complete understanding of how chronic stress modulates VTA neurons at both a molecular and physiological level. Results from these experiments will also provide candidate genetic markers for highly-targeted behavioral studies that will elucidate how discrete cell populations in the VTA orchestrate motivated behaviors under stress. Together, these aims will promote our understanding of the precise neural circuits that are dysregulated in mental illness, contributing to the search for effective treatments.

Public health relevance
PROJECT NARRATIVE The proposal I describe here is highly relevant to public health because understanding how chronic stress im- pacts VTA (1) gene expression and (2) neurophysiological adaptations in a cell-type-specific manner will shed light on the precise neural substrates of stress signaling. These findings will inform future therapeutic strategies for stress-induced disorders, such as depression, anxiety and addiction, each pervasive health issues in the US.